Imaging Core

The mission of the Imaging Core is to maintain state-of-the-art imaging platforms in support of NIDCR DIR investigators. The Core provides hardware infrastructure, research and the technical support required for investigators to apply advanced imaging modalities towards their research goals. Within this last fiscal year the Core provided imaging support for the majority of research labs in the Institute. This support included work encompassing Mechanisms of Development & Stem Cell Fate, Epithelial & Salivary Gland Biology; Immunology, Inflammation & Microbiology; Sensory Biology & Pain; and Skeletal, Matrix, & Mechanobiology. Our research support totaled over 8400 hours and over 1500 sessions of direct microscope usage by our investigators including 36 new unique users trained on our instrumentation in this FY alone.

In addition to direct imaging support, the Imaging Core also sought to provide foundational and advanced imaging concepts to the NIDCR DIR through outreach initiatives. These programs included numerous hands on equipment demonstrations of new and emerging imaging approaches, an "Ask the Microscopist" seminar series, and presentations at DIR wide seminars. This outreach offers unique opportunities for the NIDCR DIR community to learn more about how our evolving capabilities could be applied to their research programs.